Berkeley Population Center

OVERALL CORE: PROJECT SUMMARY
The Berkeley Population Center (BPC), now in its 18th year of operations, requests a five-year P2C renewal to
continue its unique contributions to population dynamics research. Taking advantage of both faculty affiliate
expertise as well as institutional initiatives, the five Primary Research Areas (PRAs) to be supported in the
renewal period continue with the five existing, well-established, thematic areas of: (1) Formal Demography, (2)
Data Science and Demography, (3) Population Health, (4) Reproductive Health and HIV, and (5) Family Policy.
Collectively these are methodological and substantive areas in which Berkeley holds academic prowess, and
to which BPC contributes essential knowledge to population science. BPC affiliates are drawn from
Demography, Public Health, Economics, Sociology, Public Policy, Social Welfare and other disciplines. Early-
stage investigators are warmly welcomed to the Center and offered extensive mentoring and financial
assistance to advance their intellectual development and research activity, fostering the development of new
cohorts of researchers, especially those from underrepresented backgrounds. The BPC offers staff support for
logistics on all aspects of research administration, real and virtual meeting space, and shares information in
various ways. BPC expands population research through expert consultation on every phase of scientific
projects, plus easy access to newly expanded top-notch physical facilities and other resources such as a data
and computing lab as well as high performance computing. These combined activities and initiatives converge
into an interlocking hub of support for interdisciplinary collaboration, intellectual interaction, and new and novel
research initiatives. The BPC is poised to continue to be a world leader in its contribution to innovative and
interdisciplinary population research that will transform how contemporary population challenges are
addressed and translated.

Public health relevance
OVERALL CORE: PROJECT NARRATIVE The Berkeley Population Center’s mission is to create and disseminate high impact research findings about population processes that relate to the health and well-being of the residents of this country and beyond. This goal is accomplished through innovative methods, population-based data and tested analytic tools, and a collaborative community of interdisciplinary researchers who focus on demography, population health, and reproductive health.